Eco-evolutionary dynamics of Escherichia coli in an island system: Environmental drivers of waterborne urinary tract infections

Project Summary:
Water may be an underrecognized but important route of uropathogen transmission
causing urinary tract infections (UTls). This realization is supported by recent reports of the
presence of uropathogens in water supplies from multiple countries, and our report of a
decrease in UTls following installation of a new water treatment plant on San Cristobal
Island in Galapagos, Ecuador. Drinking or bathing in contaminated water may expose
people to extraintestinal infections caused by Escherichia coli, the most common
pathogen associated with UTls. Studies are needed to investigate uropathogenic E. coli in
drinking water systems and links to infectious disease. The hypothesis for this work is that
waterborne exposures to E. coli are a causative agent of community-acquired UTls, driven
by environmental factors and household water use. This hypothesis will be tested in three
specific aims: (1) Model the drivers and dynamics of water system E.coli contamination, (2)
Identify socio-behavioral, epidemiological, genomic, and ecological factors associated
with E. coli UTls and evaluate water as a transmission source, and (3) Estimate the impact
of modeled waterborne E. coli exposures at points of use on UTI risk. Results from this
work have the potential to revolutionize our understanding of the etiology of UTls and the
ecology of uropathogenic E. coli. Models will also inform interventions to improve water
quality and prevent disease.

Public health relevance
Urinary tract infections (UTIs) are among the most common infections worldwide. They also account for substantial antibiotic use and contribute to the growing threat of antibiotic resistance, which poses a serious risk to American patients and modern medicine. This research will determine whether contaminated drinking or bathing water is a source of UTIs, using San Cristobal Island in the Galápagos as a model system that cannot be replicated domestically, and will generate evidence and predictive tools directly applicable to improving water safety and reducing disease burden in the United States and globally.